LUMICKS C-trap for Mechanistic Studies of Biological Systems at the University of Minnesota

Project summary
This proposal seeks the acquisition of a LUMICKS C-Trap instrument at the University of Minnesota. The
C-Trap is the only commercially available laser optical trap that combines TIRF fluorescence microscopy with
integrated microfluidics in a user-friendly, reliable, engineered instrument. Single molecule force and
fluorescence spectroscopies have transformed the fields of cellular and molecular biology, biochemistry,
biophysics, and biomedical engineering, providing answers to crucial biological and health-related questions.
These tools are currently limited to laboratories with specialized expertise and custom-built single molecule
instruments. The C-Trap is designed as a turnkey system, enabling laboratories without specific single
molecule force or fluorescence spectroscopy expertise to conduct advanced single molecule force, position,
and fluorescence localization, as well as FRET analysis, with unparalleled spatial and temporal resolution. Key
features of the C-Trap include dual optical traps for manipulating biomolecules with sub-pN force
resolution/detection; 3-color laser TIRF and widefield fluorescence detection for visualizing biological
processes; precise temperature control; micro and nano-stage control for exact sample positioning; laminar
flow microfluidics for high sample throughput and varying ambient media while maintaining molecular
interactions; and user-friendly software for integrated, controlled, and automated instrument operation. The
intuitive instrument and software interface, along with the automation package, will enable non-expert users to
run experiments and collect high-quality data with minimal training.
The proposal represents five major users (all with NIH R01/R35 funding) who will primarily use the instrument,
and eight minor users with NIH or other funding. These users come from four colleges across University of
Minnesota (College of Biological Sciences, College of Science and Engineering, School of Dentistry, and the
Medical School) and six different departments. The C-Trap will significantly advance the NIH-funded projects of
these researchers by enabling high-impact single molecule mechanobiological and fluorescence studies on a
range of important biomedical questions in areas such as cell surface mechanosensing, muscular dystrophy
pathogenesis, cytoskeletal structure and dynamics, viral assembly and cell entry and nucleic acid processing.
The major users and technical advisors possess extensive relevant expertise with the technology, and will
provide guidance to all users. The instrument will be housed in the University Imaging Center, a Nikon Center
of Excellence, which provides support and training for all of their instruments as well as expert advice and
consultation, from experiment planning to image acquisition and analysis. Establishing this resource will
significantly enhance numerous research programs at the University of Minnesota and contribute to the
discovery of impactful scientific, biomedical, and healthcare-related knowledge.

Public health relevance
Project narrative The proposal requests funds for a state-of-the-art instrument for a user group across the University of Minnesota to study cellular surface mechanobiology, DNA and RNA processing enzymes, viral entry, and proteins that engage the cytoskeleton for numerous cellular functions. The instrument will greatly enhance research capabilities to understand the mechanisms and functional deficits that lead to a broad range of metabolic, cardiovascular, neurological, and muscular diseases and cancers.